Spatiotemporal evolution and ecological dynamics of acute myeloid leukemia upon chemotherapy

ABSTRACT
Acute myeloid leukemia (AML) is the most common and fatal form of adult leukemia, with less than a quarter of
patients surviving past 5 years. Outcomes are especially poor in older patients, who are not candidates for
traditional “7+3” chemotherapy. They are also often refractory to or relapse on newer therapies such as BCL-2
inhibitor Venetoclax and hypomethylating agent Azacitidine. Patient xenograft and mouse models have shown
that the bone marrow (BM) microenvironment plays an important role in chemoresistance and relapse.
The recent emergence of spatially-resolved proteomic and transcriptomic technologies opens possibilities to
examine microenvironmental spatial relationships and cellular interactions at high resolution. Examination of
the AML BM microenvironment with these technologies, particularly in the context of chemotherapy, has yet to
be comprehensively explored. Previous work in our lab has included using CO-detection by InDEXing
(CODEX), a multiplexed immunofluorescence spatial profiling technology, to map the biogeography of the
normal BM environment, as well as a few NPM1 mutant chemoresistant AML samples. We will extend this
effort to a cohort of 30 AML patients to examine spatial patterns of the BM microenvironment to reveal its
role in AML chemoresistance and relapse. In addition, our lab has previously developed CytoCommunity, a
method for detection of tissue cellular neighborhoods, or spatial regions of distinct and homogeneous cell
type composition. These neighborhoods may indicate cell types organizing to form functional niches. Several
other tools have also been developed to perform neighborhood detection. However, none yet can integrate
neighborhood analyses across multiple samples to assess changes over time or in response to treatment. We
will develop methods for tracing neighborhood changes over time and across conditions and apply
them to our spatial analysis of AML. We will examine how AML cancer cells and other elements of the
microenvironment spatially reassort in response to various treatments through analysis of neighborhood
evolution and other spatial statistical methods. This will include subclone-level spatial analysis to identify
how intrinsic (genetic) mechanisms of resistance correlate and interact with extrinsic ones. Finally, we will use
CODEX-generated cell type labels to train a computer vision model to automatically annotate cell types on
co-registered H&E images. This will facilitate automatic cell type labeling on the vast supply of H&E images
without corresponding CODEX data, which will allow us to expand our spatial analysis to a much broader
cohort. Overall, our project aims to generate biological insights into the microenvironment’s role in AML
chemoresistance and relapse which will facilitate the improvement of treatment strategies and outcomes. In
addition, we will develop neighborhood evolution and automatic cell type annotation methods that will enhance
future research in spatial analysis of the microenvironment in leukemia and cancer more broadly.

Public health relevance
In addition to intrinsic genetic mechanisms, acute myeloid leukemia (AML) has been proposed to evade chemotherapy via formation of niches in the bone marrow microenvironment. With spatial omic technologies and through the development of methods to trace the evolution of tissue cellular neighborhoods over time, we aim to elucidate the spatial dynamics and cellular interactions within these niches. By uncovering the microenvironment’s role in AML chemoresistance, we strive to inform more effective treatment strategies and improve patient outcomes.